Support and Training for Research Independence, Diversity, and Equity (STRIDE)

Abstract
Training Navigation began at the Masonic Cancer Center together with the Center of American Indian and
Minority Health in September 2023. This process of engaging early career researchers and American Indian
and Alaska Native (AIAN) community members has led to increased collaboration, program ideas with grant
proposals, and opportunities for further collaboration. Support and Training for Research Independence,
Diversity, and Equity (STRIDE) is for Early Stage Researchers (ESRs), which includes students, staff, trainees,
residents, fellows, early stage, new, and established investigators to advance their cancer research careers.
STRIDE aims to increase diverse representation in cancer research and contribute to cancer disparities
research and equity practices. A particular emphasis is continued collaboration with the Center of American
Indian and Minority Health in a long-term strategy to attract, prepare, and support American Indian and Alaska
Native health professionals for cancer research. Simultaneously week seek to prepare ESRs to advance their
cancer research through events and seminars, peer networks, and mentoring. To sustain such efforts, we are
building support for research development for ESRs into our Education, Training, Diversity, Equity, and
Inclusion efforts. We also plan to continue to advance and expand such efforts by seeking complementary
support from a wide range of sources for sustainability and time build STRIDE into ongoing programmatic work
of the Masonic Cancer Center.

Public health relevance
Narrative Support and Training for Research Independence, Diversity, and Equity (STRIDE) will launch a new phase of training navigation for infrastructure and support for all Early Stage Researchers (ESRs), particularly those who are underrepresented and engaged in cancer disparities research. American Indian populations in Minnesota have a high incidence of lung and liver cancers with very limited participation in health systems for cancer treatments and limited representation in cancer careers and research. STRIDE efforts will focus on researcher preparation for competitive cancer research studies and collaborations that are established with trust, community support, and leverage the assets of the Masonic Cancer Center.